Ultrahigh-throughput imaging of 3D tumor microenvironment at nanoscale

Project Summary
This proposal aims to develop an integrated ultrahigh-throughput 3D volumetric super-resolution imaging system
by combining a multiscale fluorescence mesoscope with Magnify Expansion Microscopy. Current imaging
systems are largely limited to 2D tissue sections at single-cell resolution, which fails to capture the subcellular
interactions critical in cancer research. Our innovative system will allow for rapid, large-area 3D imaging with
exceptional detail, enabling the study of interactions between cancer and immune cells in situ. We will employ a
novel specimen immobilization approach, advanced fluorescence staining techniques, and a fully automated
workflow to enhance reproducibility and throughput. By using a genetically engineered mouse model of lung
cancer, we will visualize subcellular changes in immune synapses and identify distinct spatial clustering during
tumorigenesis and immune invasion. This project will advance the application of spatial biology in cancer
research, offering new insights into immune evasion mechanisms and improving immunotherapy strategies. Our
technology promises to revolutionize our understanding of cellular interactions in oncology, providing high-
precision, large-scale 3D super-resolution imaging capabilities.

Public health relevance
Project Narrative This research will significantly advance our understanding of cancer biology and improve therapeutic strategies by providing high-precision, large-scale 3D imaging of tumor microenvironments. The technology developed will enhance our ability to study subcellular interactions between cancer and immune cells, potentially leading to more effective immunotherapies and better patient outcomes.